Identification and analysis of novel tardigrade stress response mechanisms

Abstract
Cellular stability is essential for surviving extreme environments. Some cells and organisms can survive in
environments even in which their constituent parts are not stable, suggesting that cellular protectants must
exist that allow for survival in these contexts. Such protectants have the potential to be utilized for biomedical
applications like stabilizing sensitive biological materials, and the mechanisms by which they function are of
fundamental biological interest. Aim 1 of this proposal seeks to identify cellular protectants in tardigrades.
Tardigrades are invertebrates that can withstand a remarkable variety of environmental stresses including
desiccation, freezing, radiation, high pressure, and even the vacuum of space. Previous work has identified a
limited number of tardigrade protectant proteins, and remarkably these proteins can confer resistance to
desiccation in bacteria and yeast and enhanced radiotolerance in human cells. These studies lay the
groundwork to screen for novel tardigrade stress protectant proteins. Protectants of interest identified from this
screen will also be expressed in human cell culture in order to study mechanisms by which cellular stability is
established, and to identify proteins that are strong candidates for improving stability of biological samples. The
second aim of this proposal is to uncover genetic regulation of diapause – a state of suspended development
and increased stress resistance – in tardigrades. The pathways that control diapause may also regulate
production of stress protectants. Therefore, identification of conserved cell signaling pathways required for
diapause will inform future studies searching for protectants. Completion of this work will lead to identification
of novel protectant molecules and mechanisms of stress resistance that may prove useful for applications like
storage of biomaterials.

Public health relevance
Project Narrative Organisms regularly face environmental stresses and have adapted to produce protectant molecules that promote cellular robustness. Such protectant molecules can also be used for biomedical applications by stabilizing sensitive materials, like vaccines. The primary aims of this proposal are to identify protectant proteins and mechanisms of stress resistance in order to improve stability of biomaterials.